FY2024 NHANES DXA Osteoporosis Assessment Component/Study

Support for the Osteoporosis DXA Hip and Spine Component in the National Health and Nutrition Examination Survey (NHANES). To provide support to the National Center for Health Statistics (NCHS), for the Osteoporosis DXA Hip and Spine Component in the National Health and Nutrition Examination Survey (NHANES).